24th International Workshop on Long-term Complications of HIV and SARS-CoV-2

Project Summary
With the success of antiretroviral therapy (ART), comorbid diseases are now the leading causes
of death and disability in people living with HIV around the globe, including in low and middle
income countries (LMIC). Large meetings are important venues for scientific exchange regarding
the latest advances in HIV Comorbidity research, but smaller, more intimate formats that
emphasize discussion and networking are critical to the career development of HIV Comorbidity
investigators. In addition, there is a need for a forum for scientific exchange regarding post-acute
sequelae of COVID-19 (PASC), a poorly understood syndrome which may share pathogenic
features with HIV comorbidities. Our workshop, now in its 24th year and renamed the International
Workshop on Long-term Complications of HIV and SARS-CoV-2, provides <200 international
delegates with an opportunity to come together to discuss the latest findings and controversies in
HIV Comorbidity and PASC research in a one-room, two-day format. Plenary speakers are either
noted experts from outside of HIV research or HIV researchers with expertise in a specific
comorbidity. A highly interactive PASC roundtable, with 2-3 mini-talks, highlights critical and
emerging issues in the pathogenesis and management of PASC. Abstract presentations
including 26 15-minute talks and a poster session provide ample opportunity for researchers to
present and get feedback on their latest work. With this R13, we propose to enhance the 24th
Workshop (November 5th/6th in New York City) with the following aims: 1) to provide a forum for
the latest HIV Comorbidity research in LMIC by offering travel scholarships to LMIC investigators,
supporting an internationally-recognized expert in non-communicable diseases in LMIC as a
plenary speaker, and liaising with international training programs, 2) to provide a continued and
expanded forum for discussion and dissemination of the latest research findings regarding PASC,
3) to support early-stage HIV Comorbidity and PASC investigators with a scholarship program
and a Career Development Studio. By providing a “scientific home” to HIV Comorbidity and PASC
investigators from around the world, we hope to catalyze future research efforts in HIV
Comorbidities and PASC and facilitate the translation of research findings into clinical strategies
that can improve the lifespan and healthspan of PLWH and those with long COVID.

Public health relevance
Narrative The International Workshop on Long-term Complications of HIV and SARS-CoV-2 is a unique forum for scientific exchange on HIV Comorbidities and Post-Acute Sequelae of COVID-19 (PASC). We propose to enhance the 2022 Workshop by providing scholarships to early stage investigators and investigators from low and middle income countries as well as a Career Development Studio.